Contraceptive hormone impacts on the primary reinforcing and reward-enhancing effects of nicotine

PROJECT SUMMARY/ABSTRACT
Nicotine is the primary addictive agent driving chronic smoking/vaping. Women experience greater nicotine use
vulnerability, insofar that they become addicted to nicotine faster than men and exhibit higher smoking relapse
rates. Women are also at greater risk of smoking-related heart attacks, cancers, and mortality. Hormonal
contraceptives typically contain a synthetic estrogen (e.g., ethinyl estradiol or EE) and/or a progestin (e.g.,
levonorgestrel or LEVO), and are taken by 50% of premenopausal smokers. Contraceptive hormones are
associated with higher smoking rates, enhanced nicotine reward, and a greater risk of smoking-related illness
and mortality. Hormonal contraceptives are thus clearly linked with the public health burden of smoking. A
better understanding of factors driving enhanced nicotine use vulnerability amongst women, and how hormonal
contraceptives work to augment that vulnerability, would be of enormous benefit. The reinforcing effects of
nicotine are weak compared to the tenacious addiction that nicotine maintains, leading the field to seek other
factors involved in the development of nicotine use disorder. Indeed, environmental stimuli that commonly co-
occur with nicotine (e.g., smell, taste, or sight of cigarettes/vapes) have been found to play a large role in
smoking/vaping maintenance, particularly for women smokers. The enhanced import of environmental factors
in nicotine intake extends to female rats, suggesting this sex-linked disparity may be rooted in biology more
generally, or perhaps sex hormones more specifically. One such environmental factor is the enhancement by
nicotine of the reinforcing value of other rewarding stimuli. In rats, the species studied here, our lab and others
have found that responding for nicotine infusions alone was not reliably above saline suggesting a lack of primary
reinforcement by nicotine. However, when nicotine infusions co-occurred with weakly reinforcing visual stimuli
(e.g., a brief light presentation), nicotine-maintained responding increased up to eight-fold. This synergistic
effect of nicotine reward-enhancement on nicotine intake was more prominent in female rats. Using a preclinical
model of the role of reward-enhancement in nicotine intake, the proposed studies will test whether contraceptive
hormones alter nicotine intake via the direct primary reinforcing effects of nicotine, or rather via augmenting the
role of reward-enhancement in nicotine self-administration. The Specific Aims will examine the separate effects
of EE (Aim 1) and LEVO (Aim 2) on the role of reinforcement and reward-enhancement in an intravenous
nicotine self-administration task. To this end, separate groups of ovary-intact female rats will respond for
nicotine or saline infusions and will receive daily EE (Aim 1) or LEVO (Aim 2) injections before self-
administration sessions. Each rat will undergo separate conditions with access to infusions alone or infusions
delivered with a moderately reinforcing visual stimulus. We hypothesize that EE will increase and LEVO will
decrease nicotine self-administration and do so via modulating the role of reward-enhancement in nicotine self-
administration.

Public health relevance
PROJECT NARRATIVE Women experience greater nicotine use vulnerability in addition to higher rates of cancer, heart attacks, and mortality from smoking; hormonal contraceptives heighten this nicotine use vulnerability in addition to exacerbating women’s already greater risk for adverse smoking related health consequences. In turn, massive gains would result from a better understanding of mechanisms that underly this enhanced nicotine use vulnerability and its augmentation by hormonal contraceptives. The long-term objective of this research program is to provide a behavioral mechanistic understanding of how synthetic hormones contained in contraceptives influence nicotine intake, ultimately providing the preclinical basis for which researchers and practitioners can develop better cessation treatments and reduce health disparities caused by enhanced nicotine use vulnerability and comorbid contraceptive use in women.